Evolution of primate genome sequence /rearrangements

The overall aim of this project is to define the evolutionary origins of local, low-order repeated sequences that contribute to genetic diseases in humans. This project will contribute materials and expertise to project I- III and assist with characterization of sequences under study in the laboratories of Drs. Morrow, Lupski and Shaffer. In addition, this project will carry out analysis of regions of the human X chromosome that carry out similar sequences involved in genetic disease. This effort will be carried out in conjunction with a project to define the molecular breakpoint of chromosomal rearrangements that have occurred among the great apes. The data developed in this project will lead to a greater understanding of the origin of sequence subject to instability in disease. Furthermore, understanding the molecular causes and effects of genome change may lead to greater insight into the evolutionary process. Four specific aims are proposed: 1. Characterize the LCR22 from chromosome 22 in higher primates to determine their evolutionary origins. 2. Analyze the region-specific low-copy repeat gene clusters in proximal human chromosome 17 and determine their evolutionary origins. 3. Determine the subtoleromeric DNA structures on distal human 1p and analyze their structures and chromosomal distribution among the great apes. 4. Determine the evolutionary origin of two local repeats on the human X chromosome-those involved in deletions of Xp22.3 leading to steroid sulfatase deficiency and those involved in Xq28 inversions resulting in Hemophilia A. Successful completion of these aims will refine hypotheses regarding the mechanisms responsible for generating the sequences that lead to high frequency rearrangements associated with human genetic disease. It is anticipated that understanding the features involved in these regions will help to predict additional region subject to similar changes. This will in turn lead to recognition of the molecular basis for mental retardation and development of refined diagnostic assays.